Molecular mechanisms of membrane disruption induced by early-stage aggregation of beta-amyloid peptides

Project Summary
Because of the recent failures in the development of anti-amyloid therapeutic strategies for curing
Alzheimer's disease (AD), it is prompt to re-evaluate the existing amyloid cascade hypothesis from all possible
aspects. Among all these efforts, biophysical and structural characterizations of β-amyloid aggregates in in-
vitro model systems, especially the works that involve the high-resolution solid-state nuclear magnetic
resonance (ssNMR) spectroscopy, provide invaluable information from the fundamental sides. However so far,
most of these high-resolution works have been focused on the atomic structures of either amyloid fibrils or non-
fibrillar aggregates. Very little high-resolution studies have been performed to directly probe the cellular
membrane disruption effects induced by the aggregation process of β-amyloid peptides, which are potentially
associated with the neurotoxicity mechanisms of the β-amyloid aggregates.
A major challenge that prevented the high-resolution studies of β-amyloid-peptide-induced membrane
disruption effects in model systems was the heterogeneity, which usually involved co-existence of multiple
membrane disruption pathways with mixed intermediate structures. This proposal attempts to solve this
problem by generating model systems with distinct predominant membrane disruption effects. These model
systems, which contain different β amyloid aggregates and phospholipid liposomes, are characterized by
distinct time-dependent membrane disruption features and structurally homogeneous endpoints. Therefore,
they can be studied individually in terms of their membrane disruption effects using high-resolution ssNMR
approaches.
The outcomes of this proposal, if successful, will provide crucial insights on the high-resolution
molecular interactions between β amyloid aggregates and membranes that are responsible to the membrane
disruption. These information help to explain the neuronal cellular toxicity of β-amyloid aggregates, which
further contribute to the re-evaluation of amyloid cascade hypothesis.

Public health relevance
Project Narrative This project focuses on the high-resolution studies of molecular interactions between β-amyloid aggregates and membranes that lead to membrane disruptions. The outcomes will shed lights on the neurotoxicity mechanisms of β-amyloid peptides, and their pathological roles in Alzheimer's diseases.